The role of lipid metabolism in lung macrophage activity and phenotypes during acute lung injury

PROJECT SUMMARY/ABSTRACT
Metabolic programming is a critical regulator of inflammatory responses. Prior work has shown that changes in
metabolism drive changes in macrophage activity. These metabolic changes are not only a consequence of
polarization but also drive macrophage function. Downregulation of fatty acid oxidation within pro-inflammatory
macrophages leads to enhanced lipid synthesis, including production of pro-inflammatory lipid mediators. The
majority of these studies have been performed in bone marrow-derived macrophages (BMDM), and questions
remain as to how metabolism regulates the activity of lung macrophages during influenza A virus (IAV) infection.
Within the lungs, macrophages play a critical role in host defense and mediate lung inflammation and resolution.
Lung macrophages can be classified as tissue resident alveolar macrophages (AM), interstitial macrophages,
and monocyte-derived macrophages. Recent work has demonstrated significant differences in the metabolism
of AM and BMDM. Unlike BMDM, pro-inflammatory AM do not upregulate glycolysis, and in fact upregulation of
glycolysis is associated with a pro-repair or pro-fibrotic phenotype. Our preliminary data indicate that there are
significant differences between AM and BMDM not only in glycolysis but also in lipid metabolism. AM have a
higher concentration of metabolites involved in fatty acid oxidation and have higher mRNA expression of the
enzymes Cpt1a and Cpt2, which are rate limiting enzymes for fatty acid oxidation that act sequentially to transport
fatty acids from the cytosol into the mitochondrial matrix where fatty acid oxidation occurs. In addition to serving
as a source for ATP, lipid metabolism also generates lipid mediators that have important roles in cell signaling,
cytokine production, and apoptosis. Thus, our proposal focuses on understanding how changes in lipid
metabolism alter the activity and function of lung macrophages during homeostasis and injury. Our hypothesis
is that fatty acid oxidation is critical for resolution of lung injury by modulating the activity of lung
macrophages and reducing production of pro-inflammatory lipid mediators. In Aim 1, we will determine
the role of fatty acid oxidation on lung macrophage activity during IAV infection. We will utilize LysM-Cre Cpt1afl/fl
mice, which have a macrophage-specific deficiency in fatty acid oxidation. After inoculation with IAV, the clinical
and inflammatory responses and severity of lung injury will be assessed at multiple time points. Lung
macrophage subsets will be isolated and their transcriptomes profiled by RNAseq. In Aim 2, we will determine
how fatty acid oxidation regulates the metabolic activity of lung macrophages by performing unbiased
metabolomics on isolated lung macrophage subsets during IAV infection. The extracellular microenvironment
will be assessed by determining the metabolome of the bronchoalveolar lavage fluid. These studies build upon
work done in my K08 award and expand our focus to fatty acid oxidation and lipid metabolism. These data will
serve as a foundation for an R01 proposal aimed at understanding how changes in metabolism regulate lung
macrophage activity during injury.

Public health relevance
PROJECT NARRATIVE Lung macrophages play a critical role in host defense from influenza A virus (IAV), which remains a significant cause of morbidity and mortality worldwide. Metabolism is a key regulator of macrophage responses, but questions remain as to how lipid metabolism mediates the macrophage response to IAV. In this proposal, we will study the role of fatty acid oxidation on the metabolism and function on lung macrophages during IAV infection.